Ramping time scale synaptic plasticity in the in vivo cerebellum

Long-term depression (LTD) at cerebellar parallel fiber (PF) to Purkinje cell (PC) synapses has been studied in
great detail, because a) it constitutes a major form of cerebellar plasticity that may underlie various forms of
motor adaptation and learning, b) it may initiate synaptic pruning and thus shaping of essential connectivity,
and c) it provides the perhaps best example of supervised learning due to is dependence on co-activity of the
climbing fiber (CF) input. According to the theories of Marr, Albus and Ito, the instructive CF signal in some
conditions presents an error that for its correction requires a change in PF synaptic input weights. LTD has
been first described in vivo in decerebrate rabbits. Most subsequent studies have been performed in slices,
where whole-cell patch-clamp recordings from PCs enabled a characterization of LTD in molecular detail. The
goal of this study is to assess the conditions under which LTD is evoked in the cerebellum of intact mice. The
motivation to do so is twofold, one is more general, and one specific. First, we have recently determined LTD
induction rules in slice, but under more realistic (physiological) recordings conditions, including the use of an
accurate extracellular ionic milieu ([Ca2+]o =1.2mM; [Mg2+]o =1.0mM) and near-physiological bath temperature.
These ‘updates’ changed LTD rules substantially, and we became aware that recordings in vivo might reveal
further differences to the current understanding. Second, a new physiological phenomenon has been observed
in vivo that we predict will have a substantial impact on LTD: ramping in the activity of granule cell / PC activity
over hundreds of milliseconds up to seconds, which was described during motor planning and in learned
behaviors triggered by sensory cues. As a result of prolonged calcium elevation, we predict a shift in plasticity
threshold values via a ‘leaky integrator’ mechanism. We will use two-photon measurements of GCaMP7b-
encoded calcium transients in PC dendrites (PC-specific promoter L7) to compare plasticity outcomes between
classic PF single-pulse or burst / CF protocols and new protocols, in which prolonged PF activity ramps are
paired with CF stimulation (aim 1). Here, the PF and CF inputs are electrically stimulated, and plasticity is
determined by a dendritic calcium signal measure. We will pair this approach with patch-clamp recordings from
PCs in slices, where we mimic ramps by PF stimulation (aim 2). This approach is important to obtain an
electrophysiological LTD readout from the somatic patch electrode that complements the imaging results
obtained in vivo. Prolonged PF ramps lasting ³ 1s will be ‘interrupted’ by spontaneous CF-evoked complex
spikes. There is no current hypothesis of the purpose of these complex spikes, but we do hypothesize that
their firing erases prior calcium build-up that results from ramping (‘windshield wiper effect’). Using both in vivo
and in vitro imaging approaches, we will study how interfering complex spikes affect PF ramps and plasticity
outcomes (aim 3). This study will be the first to assess cerebellar LTD in intact mice with consideration of
activity ramping, a motif in temporal input structures that is typical for learned PF input patterns.

Public health relevance
The cerebellum is an evolutionary old brain area, whose role in sensorimotor integration and motor learning is well studied. Underlying this function in motor learning is a cellular supervised plasticity mechanism – the best- known component of it is climbing fiber-promoted synaptic long-term depression (LTD) at parallel fiber synapses onto Purkinje cells – which also plays a role in cognitive functions: LTD dysregulation is observed in autism spectrum disorder (ASD). Here, we propose to study LTD in awake mice to obtain a first comprehensive characterization of LTD properties and induction conditions in vivo with attention to neural activity patterns (prolonged ramping) that we suspect to have substantial effects on associative learning rules.